Multilingualism as a factor of resilience to Alzheimer's disease and related dementias in India

Project Summary/Abstract
By 2050, two-thirds of older individuals with dementia will live in low-and middle-income countries (LMICs). As
LMICs continue to experience a reduction in mortality, it is critical to determine factors that confer protection and
resilience toward Alzheimer’s disease and related dementias (ADRD). Some studies find that bilinguals are at
reduced ADRD risk compared to monolinguals, but other studies do not find evidence of a bilingual advantage.
The rationale for this study is that the equivocal findings of prior research has been driven largely by
methodological inconsistencies that limit our understanding of bilingualism’s role in cognitive aging such as: 1)
inadequate control for potential confounders that limit our ability to infer whether bilingualism has a direct effect
on cognition or whether these relationships are due to environmental and sociocultural factors, 2) limited
inclusion of markers of neuropathology, and 3) little attention given to within-group differences among bilinguals,
such as age of second language (L2) acquisition, proficiency, frequency of language use, number of languages
spoken, and diversity of language families. India offers a unique opportunity to study the role of bilingualism in
cognitive reserve and resilience, given its rich linguistic and sociocultural diversity across the country. The overall
aim of the study is to leverage the unique features of India’s linguistic and sociodemographic landscape to
discern whether bilingualism modifies the association between blood-based and neuroimaging biomarkers of
ADRD and cognition and cognitive decline. This study will analyze available plasma-based measures of amyloid
and tau pathologies, MRI, and cognitive assessments from the Longitudinal Aging Study in India–Diagnostic
Assessment of Dementia (LASI-DAD), a large, population-representative study of ageing and dementia in India.
Specifically, the project will 1) determine whether bilingualism modifies the association between ADRD
biomarkers (blood-based or neuroimaging) and cognitive outcomes, 2) evaluate whether the protective effect of
bilingualism differs across diverse life-course environmental determinants of health, and 3) deconstruct language
use within bilinguals in India to understand the mechanisms by which bilingualism confers cognitive reserve
against biological risk of ADRD. We hypothesize that bilingualism will buffer the effects of blood AD-biomarkers
(amyloid, and tau plasma levels), cortical atrophy, and white matter integrity on baseline cognition and rate of
cognitive decline compared to monolinguals in the domains of memory, language, and executive functioning. In
addition, by deconstructing bilingualism, we hypothesize that earlier age of L2 acquisition, higher bilingual
proficiency, greater daily multiple language use, higher number of languages acquired, and greater distance
between language families will confer cognitive reserve, independent of confounding sociocultural factors (i.e.,
education, socioeconomic status). This proposal will enhance the field of ADRD by uncovering the underlying
mechanisms of resilience to ADRD that may be modifiable and transferable to other populations.

Public health relevance
Project Narrative India provides a unique context with which to disentangle the effect of bilingualism on cognitive aging because bilingualism is much more equally distributed among socioeconomically diverse groups in India than it is in Western and high-income countries. Leveraging already-funded, rich population representative data from India, the findings of the proposed investigation will yield new insights on the intersection of bilingualism and cognitive aging, discerning whether bilingualism buffers the effects of blood-based and neuroimaging biomarkers of Alzheimer’s Disease and Related Dementias (ADRD) and uncovering the mechanisms by which bilingualism confers cognitive reserve against biological risk of ADRD.